Dissecting metabolic control by cytosolic-mitochondrial NAD compartmentalization

Abstract
Nicotinamide adenine dinucleotide (NAD+) is a cofactor and signaling molecule that regulates critical processes from
DNA repair to axon degeneration. NAD+ levels decline with mitochondrial dysfunction, in aging, and in various age-
related pathologies. Moreover, studies have repeatedly shown that increased NAD+ levels are beneficial for cellular
and organismal healthspan. Multiple cellular compartments contain NAD+-synthesis and NAD+-consuming signaling
proteins, but little is known about the mechanisms by which NAD+ concentrations in each organelle are appropriately
tuned to metabolic and signaling demands. Mitochondria harbor up to 70% of cellular NAD+, and NAD+ acts as an
electron carrier in mitochondrial respiration and as a signaling molecule through the mitochondrial sirtuins. However,
it is not known how the mitochondrial NAD+ pool is established and maintained or how it contributes to cellular
metabolic control. Using gene co-essentiality analysis, we recently identified a mitochondrial transporter, SLC25A51,
required for the uptake of NAD+ into mitochondria. We hypothesize that SLC25A51 is a major factor in cellular NAD+
compartmentalization and a critical player in metabolic homeostasis and a cell’s response to stress. A major long-
term goal of our research program is to understand how cells regulate their mitochondrial NAD+ pool and NAD+
compartmentalization to control metabolism and signaling in health and disease. In the next five years, we will focus
on three areas outlined in this proposal: 1) understanding the biochemical mechanism and driving forces of
mitochondrial NAD+ transport by characterizing the activity of SLC25A51 in cell-free proteoliposome transport
assays; 2) determining how mitochondrial NAD+ transport is regulated, by identifying the signaling pathway and
transcription factors that regulate SLC25A51 expression and by elucidating how the protein is turned over in or
removed from the inner mitochondrial membrane; and 3) delineating how cytosolic-mitochondrial NAD+
compartmentalization contributes to metabolic regulation in the liver using SLC25A51 loss-of-function mouse
models. The results of our studies will provide important insights into the mechanisms of cellular NAD+
compartmentalization and identify new modes of metabolic regulation relevant for human disease. This research
program is aligned with our laboratory’s overall goals to understand the mechanisms of metabolic
compartmentalization, and specifically the role of mitochondrial transporters, in adjusting mitochondrial function to
metabolic demands and cell state, and responding to stress.

Public health relevance
Project Narrative Mitochondria are responsible for generating the majority of the energy and building blocks in cells, and alterations in mitochondrial function are linked to many diseases, including cancer, diabetes, and neurodegenerative disorders. Little is known about how mitochondria take up nicotinamide adenine dinucleotide (NAD) – a cofactor in redox metabolism and metabolic signaling – and adjust this uptake in response to metabolic demands. Our studies will elucidate the mechanisms of cellular NAD compartmentalization, identify new modes of metabolic regulation, and unravel how modulation of NAD levels contributes to human physiology and disease.